Intervening with Opioid-Dependent Mothers Living in Poverty: Effects on Mothers' and Infants' Behavioral and Biological Regulation

Opioid use has increased dramatically in recent years, with rates especially high among women living
in poverty. Maternal opioid use combined with poverty renders children highly vulnerable to a host of
short- and long-term challenges developing self-regulatory capabilities. In infancy, challenges in self-
regulation can be seen in problems in the regulation of attachment behaviors, autonomic nervous
system activity, and production of steroid hormones. Sensitive parenting is especially important for
such children. Without intervention, many children born to opioid dependent mothers are unlikely to
receive sensitive parenting. Early intervention is needed that helps these mothers provide sensitive
care despite the challenges of substance use. In this project, we will assess the efficacy of a home
visiting program adapted for mothers with opioid dependence who are living in poverty. Mothers on
medication assisted treatment for opioid dependence during their third trimester of pregnancy will be
randomized to this adapted home visiting program, modified Attachment and Biobehavioral Catch-up
(mABC: N=100), or to a control condition of the same duration and frequency (modified
Developmental education for Families, or mDEF: N=100). We will assess whether the mABC
intervention engages the purported treatment mechanism, maternal sensitivity. Second, we examine
whether the intervention has positive effects on infants’ regulation of cortisol production, autonomic
nervous system activity, and attachment. Third, we examine whether maternal sensitivity mediates
intervention effects on infant outcomes. An exploratory aim examines whether the intervention alters
maternal neural activity related to the rewarding nature of babies versus drugs. Parental sensitivity
will be assessed prenatally, and at infant ages of 1 week, and 3, 6, and 12 months of age, and
maternal neural activity will be assessed prenatally and at infant age of 12 months. Infant cortisol will
be assessed at 3, 6, and 12 months, autonomic nervous system regulation at 6 and 12 months of
age, and attachment at 12 months. The mABC intervention is expected to affect child behavioral and
biological outcomes with these effects mediated by maternal sensitivity.

Public health relevance
Infants born to opioid-dependent mothers living in poverty are at risk for a host of developmental problems, but effects can be buffered if mothers interact with their children in sensitive ways. This project assesses the efficacy of an intervention that targets parental sensitivity and is tailored to the needs of opioid-dependent infants. Effects are expected to be seen on maternal sensitivity and neural activity and on infant behavioral and biological outcomes.